The Mutant Mouse Resource and Research Center at the University of Missouri

PROJECT SUMMARY - OVERALL
The Mutant Mouse Resource and Research Center (MMRRC) is the nation’s largest public mutant mouse archive
and distribution repository organization. The primary goal is to facilitate research by identifying, acquiring,
evaluating, characterizing, cryopreserving, and distributing mutant mouse strains to qualified biomedical
investigators. The MMRRC was established by the NIH to ensure the preservation, dissemination, and
development of valuable mutant mouse lines and data generated by research scientists. The MMRRC is a
consortium of four Centers, each hosting an archive and distribution repository, and an Informatics Coordination
and Service Center (ICSC) within a trans-national network regionally distributed across the United States. The
Centers collectively serve the needs of the nation’s biomedical research community, ensuring access to and
optimizing utilization of unique transgenic, knockout, and other genetically modified mutant mice and related
biomaterials, services, and new technologies. The Centers collectively import, verify, maintain, and distribute
mice, gene-targeted embryonic stem (ES) cells, and germplasm of genetically unique, scientifically valuable
mice. Centers also provide services and procedures to assist investigators using genetically altered mice for
research. Finally, Centers conduct resource-related research, often collaboratively, to further refine and develop
mutant mouse lines to improve the reproducibility and translatability of mouse models for biomedical research.
By depositing their mutant mice in repositories at the Centers, NIH-funded investigators fulfill their obligation
under the NIH Sharing Policy. In return, each of the Centers strives to preserve the unique genetics, protect the
germplasm, assess the genetic quality, and provide these models for the benefit of research scientists and
investigators across the nation and the globe. In doing so, the MMRRC preserves the investment NIH made in
these models and ensures that valuable mutant mouse lines are available equitably across the biomedical
research community, thereby accelerating the pace of rigorous reproducible research and discovery using
genetically unique mice.

Public health relevance
PROJECT NARRATIVE Genetically-engineered mice serve as instrumental tools to understand human development, disease processes, and to develop and improve therapeutics. The Mutant Mouse Resource and Research Center at the University of Missouri provides a unique repository for importing, storing, validating, and distributing a vast number of genetically-engineered mice, germplasm, embryonic stem cells and related reagents. The center also performs critical broad-based research and services to ensure quality, reproducibility, and translatability of mouse models with an emphasis on the role of complex gut microbiota in model phenotypes.